LA’s Biostatistics Education Summer Training Program (LA’s BEST @USC)

ABSTRACT Health disparities in our nation are acute and a multi-faceted approach is needed to properly tackle this growing problem. Increasing the diversity of biomedical research scientists is one key strategy to address this crisis. With the current deluge of health-related data and a projected 34% growth in the job market for statisticians from 2014 to 2024 (Bureau of Labor Statistics), now is the time to diversify our biostatistics workforce. Herein, we plan to expand the pool of students from underrepresented groups in biostatistics by introducing a new curriculum for teaching methodologies in biostatistics, LA’s Biostatistics Education Summer Training Program at the University of Southern California (LA’s BEST @USC), with a focus on current research challenges in the study of heart and lung disease. The Division of Biostatistics in the Department of Preventive Medicine of the University of Southern California (USC) is uniquely positioned to attract talented prospective biostatisticians from underrepresented groups into the field due to its success in graduate level training since 1976, location in the ethnically diverse LA Basin, multi-disciplinary research in diverse populations, and real-life oriented approach to biostatistical research. The faculty has expertise in epidemiological methods, spatial statistics and clinical trials, and has an NIH-funded P01 to develop novel statistical methods for integrative genomics. Training a diverse workforce of scientists requires a diverse faculty. A team of faculty from backgrounds including women, African, Latino, Japanese-American, and first in their family to attain a college education, who all share a tradition of individual hands-on research mentorship and extensive portfolios of research grant support in biostatistics, epidemiology, clinical trials, is amassed and available to trainees. With this team, we propose following specific aims: 1) To identify and recruit high-quality and highly-motivated college undergraduate students from underrepresented groups. 2) To provide the trainees with courses and hands-on training in biostatistics. 3) To provide mentoring and professional development training. 4) To track LA’s BEST trainees through completion of their undergraduate degree, post-graduate education, and to their first employment.

Public health relevance
NARRATIVE Health disparities in our nation are acute and increasing the diversity of biomedical research scientists is one key strategy to address this crisis. With the current deluge of health-related data and a projected 34% growth in the job market for statisticians from 2014 to 2024 (Bureau of Labor Statistics), now is the time to diversify our biostatistics workforce. Herein, we plan to expand the pool in biostatistics of students from underrepresented groups by introducing a new curriculum for teaching methodologies in biostatistics, LA’s Biostatistics Education Summer Training Program at the University of Southern California (LA’s BEST @USC), with a focus on current research challenges in the study of heart and lung disease.